Randomized controlled trial of an internet-based prevention intervention for young children at-risk for functional abdominal pain

PROJECT SUMMARY
Exposure to a parent with chronic pain in childhood is one key risk factor for pain and adverse mental and
physical health outcomes among children. In particular, having a parent with Irritable Bowel Syndrome (IBS),
an idiopathic chronic abdominal pain disorder, places children at 2x greater risk for developing an abdominal
pain disorder. Our own research has demonstrated that pain-specific social learning is highly influential in this
intergenerational transmission. However, there is essentially no previous research that has attempted to
intervene with parents to prevent illness behaviors in early childhood, when these illness behaviors often
emerge and become established. Our team has developed and tested social learning and cognitive behavioral
therapy (SLCBT) interventions to change parental behaviors and modeling in order to reduce children’s illness
behaviors. We hypothesize that SLCBT can be modified toward a preventive focus for parents with IBS who
have young asymptomatic children, ages 4-6 years, in order to reduce risk factors (anxiety, catastrophizing,
parenting stress) and increase protective factors (positive affect, social support), resulting in fewer abdominal
pain symptoms in children, reduced health care utilization, and less health-related disability. Therefore, the
objective of the current application is to test the efficacy of an early preventive intervention targeting parents
with IBS whose young children are thus at higher risk for developing illness behavior and subsequently a
diagnosis of a chronic abdominal pain disorder. To enhance potential for scalability and dissemination, and
meet parental preferences, we propose delivering the intervention via the internet through approaches our
team has successfully used with other psychosocial pain interventions. The study design is a randomized
controlled trial with parallel 1:1 assignment to two study arms, 1) attention education control, and 2) SLCBT
prevention intervention. We aim to recruit 460 parents with IBS who have young children ages 4-6 years.
Participants will be assessed at baseline, 6-week (immediate post-intervention), 6-month, 12-month, and 18-
month follow-up periods. All study procedures will be conducted remotely using digital platforms and web-
based technologies. Social media ads will be used to advertise the study and recruit participants. The primary
outcome is change in parental solicitous/protective behaviors. Secondary outcomes include parent risk and
protective factors and child health and symptom outcomes. We will determine cost savings of implementing
this preventive intervention on health care expenditures and resource utilization over 18 months. The proposed
study will be the first to evaluate the potential benefit of an early preventive psychosocial intervention
specifically for children at risk for a common pediatric pain condition. If successful, this study has high potential
impact to provide a model for a preventive intervention for a wide range of pediatric health problems which can
impact functioning beyond childhood in which parental responses are influencing factors.

Public health relevance
PROJECT NARRATIVE Chronic pain often clusters in families, where parents and their offspring both experience chronic pain conditions. Young children of parents with irritable bowel syndrome represent an at-risk group for the development of abdominal pain, disability, and excess health care visits in later childhood. Parental solicitous responses to children’s expressions of discomfort and maternal modeling of their own illness behavior contribute to a greater focus on somatic sensations, leading to illness behaviors in children. We hypothesize that an early preventive psychosocial intervention specifically for children at risk for an abdominal pain disorder can alter parental responses and lead to improved child health and decreased health care costs.